NJDA Animal Health Diagnostic Lab - FDA CVM Veterinary Diagnostic Program Co-operative Agreement to Protect Public Health

Project Summary
The Animal Health Diagnostic Laboratory (AHDL) at the New Jersey Department of Agriculture
(NJDA) seeks to participate in the Center for Veterinary Medicine (CVM)’s Veterinary Diagnostic
Laboratory Program. The aim of the project is to improve the infrastructure capabilities of the
AHDL to respond to potential outbreaks or incidents involving contaminated animal food or drug.
The NJDA AHDL’s objective in participating in the CVM Veterinary Diagnostic Laboratory
program is to obtain the equipment, supplies, personnel, and training in standardized testing
methodologies.
The AHDL will participate in case investigations by engaging in sample analyses, necropsy, and
histopathology services. The AHDL will participate in method development, method validation,
animal food/drug defense assignments, tissue/slides sharing, bacterial isolates sharing, training,
and proficiency testing when available. The AHDL will provide surge capacity as needed by the
Vet-LIRN/FDA in the event of a large-scale microbiological or chemical terrorism or natural
pathogenic organism outbreak events affecting animal food or drug products. The AHDL will
share results of method development, method validation, and matrix extension studies with Vet-
LIRN Program Office (VPO) and network laboratories as determined by the VPO. The AHDL will
also provide antimicrobial susceptibility and whole genome sequencing capabilities including
sharing the susceptibility data and relevant metadata.
The AHDL has required laboratory staffing, equipment, facilities, and professional expertise to
fulfill its obligations under the CVM Veterinary Diagnostic Laboratory program.

Public health relevance
Project Narrative Serving a densely populated state with a diverse population of pets and livestock, the Animal Health Diagnostic Laboratory (AHDL) at the New Jersey Department of Agriculture (NJDA) has a responsibility to safeguard the health and well-being of not only the animal population, but also the human population. When animal food or drug products are contaminated, human health may be compromised either through consumption of contaminated products or by consuming ingredients used in both animal and human products. The equipment, supplies, personnel, and training supported by the co-operative agreement funding will improve the capabilities of the AHDL to a) respond to animal food and drug contamination events, potential outbreaks, and incidents needing surge capacity b) provide analytical data for regulatory purposes, and c) participate in interlaboratory method comparison, small-scale method development and/or validation, and matrix extension